IMP: Software for Hybrid Determination of Macromolecular Assembly Structures

Project Summary
The broad goal is to develop and apply computational methods for building structural models of proteins and
their assemblies. One successful approach, integrative structure modeling, casts the building of such models as
a computational optimization problem where knowledge about the assembly is encoded into the scoring function
used to evaluate candidate models. We propose to extend and enhance the Integrative Modeling Platform (IMP)
program that provides programmatic support for developing and distributing integrative structure modeling pro-
tocols. IMP already allows representing molecules at multiple resolutions, using spatial restraints from many
types of data, and searching for solutions by a variety of sampling algorithms. So far, it has been applied mostly
to data from electron microscopy (EM), mass spectrometry, small angle X-ray scattering, Förster resonance
energy transfer, crosslinking, hydrogen deuterium exchange (HDX), and various proteomics methods. IMP is
easily extensible to add support for new data sources and algorithms, and is distributed under an open source
license. Here, we propose to extend IMP to address a greater range of biological problems and make it
more generally useful to the scientific community. Specifically, in Aim 1, we will develop integrative threading
for computing an atomic model based on a density map determined at medium resolution (4-8 Å) by EM or X-
ray crystallography. This goal will be achieved by simultaneously sampling both threading and conformation
based on the density map as well as other data, such as chemical cross-links and HDX protection factors. This
method is significant because it will produce atomic resolution models from medium-resolution maps determined
by either EM or X-ray crystallography. In Aim 2, we will develop a Bayesian integrative method for modeling
ensembles of similar systems. Data from different samples, ensembles, and/or variants are often pooled together
to model a single representative structure. This synthesis is problematic when the variation between the actual
structures across the samples, ensembles, and variants is larger than the uncertainty of the data. We will address
the challenge by developing a general and flexible scheme for representing and scoring related structural en-
sembles. This method is significant because it will improve the accuracy of the model and the estimate of its
uncertainty. In Aim 3, we will maximize the impact of IMP on the community, by delivering a well-tested and
maintained software package that is documented with mailing lists, examples, and demonstrations at local and
external workshops, by hosting select users at UCSF, and by pursuing closer integration with other software
packages and community resources, including databases such as the Protein Data Bank (PDB), structure view-
ers such as Chimera and VMD, and other modeling programs such as NAMD and ReaDDy. The proposed aims
are informed by and will shape the nascent worldwide PDB effort on representing, validating, archiving, and
disseminating integrative structure models.

Public health relevance
Project Narrative / Relevance We propose to extend IMP, an open source computer program for determining the structures of macromolecular machines based on varied data from multiple experimental methods. The resulting structures will allow us to better understand the workings of the cell, both under normal and disease conditions.